TOBACCO RELATED MALIGNANCIES PROGRAM

Description: (Applicant's Description) The overall goal of the Tobacco Related Malignancies Program is to decrease the incidence, morbidity, and mortality of tobacco induced cancers of the aerodigestive tract. The Program is comprised of 28 investigators with interests in various aspects of carcinogenesis, genetics, cell signaling/biology, clinical trials and primary prevention/screening/early detection. The Program includes both basic and clinical scientists with complementary interests. Clinical specialities include Medical Oncology, Radiation Oncology, Pathology, Pulmonary Medicine, General Internal Medicine, Psychiatry, Immunology, Dentistry, Head and Neck and Thoracic Surgery. Interactions between members are promoted by a twice-monthly research seminar, day-long or half-day symposia and individual outside speakers. A weekly Pulmonary/Thoracic/Oncology multidisciplinary conference and a weekly Head and Neck Tumor conference promote the enrollment of patients onto therapeutic trials. A Career Development Program has been successful in supporting young faculty members who have gone on to careers in research related to tobacco induced cancer. A Developmental Program has supported pilot projects, several of which have subsequently resulted in independent funding. Several novel therapeutic strategies based on basic and preclinical work at our institution are now being translated to human trials, including one supported by an NCI RAID. In addition to individual research grants, interactions between program members have resulted in several multi-investigator proposals, including a Specialized Program of Research Excellence in Lung Cancer, Genetic Epidemiology of Lung Cancer Consortium, Lung Cancer Biomarkers and Chemoprevention Consortium, a Biomarkers Development Component of the Early Detection Research Network and an NCI/NIDA Transdisciplinary Tobacco Use Research Center; all but the last of these were fully funded. Several parts of the latter were funded as were several other tobacco projects described in the Clinical and Community Prevention and Control Programs.